Core D

PROJECT SUMMARY
The research projects proposed in the Program encompass a wide spectrum of translational AML research
activities, ranging from studies in cell lines, animal models, clinically and molecularly annotated tumor samples
and other biospecimens, and clinical studies. These studies will generate many different types of data, including
biological, clinical, genomic, metabolomics, and molecular data. The Biostatistics and Data Management Core
(Core D) will function as a centralized research design and data analytics support team to ensure proper study
design, data integrity, accuracy of data analysis, and data management capacity for studies performed within
the Program Projects.
Core D members will (1) provide biostatistical support for experimental design, power calculation, data
analysis, and interpretation for all Program Project research activities, (2) develop or implement novel statistical
methodology in support of the scientific objectives of the Program Projects, and (3) provide overall data
management and sharing support for all Program Projects. Core D will provide expertise in statistical design,
analysis and interpretation of studies as well as the programming and data management expertise needed to
ensure rigorous research and promote synergies among the Projects and Cores.
Core D will provide comprehensive, efficient, and cost-effective support for innovative translational AML
research, ensuring rigor and transparency of analysis, management, and sharing of the data generated by the
Program and reproducibility of the analysis results.

Public health relevance
PROJECT NARRATIVE The Biostatistics and Data Management Core will function as a centralized research design and data analytics support team to ensure proper study design, data integrity, accuracy of data analysis, and data management capacity for studies performed within the Program Projects. The Core will provide comprehensive, efficient, and cost-effective support for innovative translational AML research, ensuring rigor and transparency of analysis, management, and sharing of the data generated by the Program and reproducibility of the analysis results.